Nanotechnology-based personalized treatment of metastatic ovarian cancer

This is an application for an interdisciplinary project to develop a novel approach for personalized chemotherapy
of gynecologic cancers. Estimates from the National Cancer Institute indicate that more than 116,000 women in
the United States will be diagnosed with a gynecologic cancer and about 34,000 die from these types of cancer
in 2021. Despite advances in surgical and radiation treatments, chemotherapy continues to be an important
treatment option for gynecologic malignancies, especially for locally advanced and metastatic tumors. However,
the efficacy of chemotherapy is substantially limited by the intrinsic and acquired resistance of cancer cells to
cytotoxic drugs. We are proposing to develop and validate a nanotechnology-based approach of personalized
treatment of ovarian carcinoma (most lethal type of gynecological cancers) constructed on the individual genetic
profile of the patient’s tumor. Based on the results of the present translational research the following treatment
protocol will be proposed for future clinical trials after the completion of the present project. Samples of a patient’s
tumor and normal surrounding tissues will be obtained during the tumor debulking surgery and tumor profile data
(the expression of predefined genes and proteins) will be obtained and analyzed. Based on this analysis, several
molecular targets and the most effective anticancer drug(s) will be selected. Finally, a mixture of complex
nanocarrier-based targeted delivery systems (TDS) containing drug(s)/siRNA(s)/targeted peptide will be
selected from the pre-synthesized bank and the patient will be treated with the chosen cocktail of TDS designed
specifically for their individual tumor. The selected systems will include the lipid-based carrier, the tumor targeting
moiety, the most effective drug(s) and siRNA(s) selected for each individual patient based on a genetic profile of
the patient’s tumor. It is expected that such personalized therapy will effectively suppress drug resistance and
tumor growth, inhibit the development of metastases and limit adverse side effects of therapy in the particular
patient. The main goals of the proposed research are to identify profiles of gene/protein expression in tissue
samples isolated from patients with ovarian cancer that predict tumor response and resistance to anticancer
drugs with different mechanisms of action. We also will develop a set of TDSs containing anticancer drug(s) or
siRNA(s) targeted to different mRNAs overexpressed in the tumor of the patient. Finally, a genetic profile and
protein expression phenotype will be performed on samples of tumor tissues and malignant ascites from patients
with ovarian carcinoma. Cancer cells will be isolated from fresh samples obtained during surgery. Based on the
results of the genetic profiling, a mixture of TDS will be created and tested in vitro (on cell culture model) and in
vivo (on subcutaneous murine cancer model) using cancer cells isolated from each individual patient and
recommendations for the personalized treatment of ovarian cancer will be developed.

Public health relevance
Relevance to Public Health The efficiency of chemotherapy for gynecological cancers varies substantially from patient to patient because mechanisms of tumor development, drug resistance and rate of proliferation can be significantly different in each patient. We propose to select anticancer drug(s) and suppressors of cellular proliferation, drug resistance and metastases (i.e. nucleic acids) based on an individual genetic profile, determined in tumor tissues obtained from patients with gynecological cancers. It is expected that the proposed individualized treatment for gynecological malignancies will substantially enhance therapeutic efficacy of chemotherapy and will be effective for every particular patient.